Medical Scientist Training Program

Project Summary
This proposal requests support for the MSTP at the University of Cincinnati College of Medicine (UCCOM).
Our dual-degree program was established in 1985 and has been continuously NIH-funded for over 15 years. It
enrolls 9 new students each year and currently includes 55 students. The central goal of the UCCOM MSTP is
to train physician scientists who will be the leaders in their respective fields in academic medicine.
Our Program is supported by a solid infrastructure in clinical and research training. Our students can
choose from 10 diverse graduate programs. The success of our Program is best illustrated by the success of
our graduates. Of our 94 graduates, 52 (79%) remain in academia or in research intensive careers in industry
or government and 32 of these (62%) have research funding from the NIH, industry or government. Alumni
from our program are likely to work in full-time academic medicine; 49 or 74% of graduates remain in academic
medicine, and notably 29 (59%) of these have NIH funding to support their research. In addition, 3 of our
alumni hold leadership positions in government or industry.
Our students come from a diverse applicant pool drawn from across the nation. For the class that
matriculated in the Fall of 2016, we had 187 applicants from 34 states. Our current MSTP students include
18% URM and 16% disadvantaged/disabled students. The average time to complete our MSTP for the last 10
years is 8.1 years and our students have matched at the most competitive residency programs.
Since the last funding period, several important and exciting developments have taken place, which include
increases in the size and quality of our applicant pool including URM and disabled/disadvantaged applicants,
our program faculty, extramural research support among our program faculty, flexibility in the M3/M4
curriculum for MSTP students, number and breadth of training opportunities for MD/PhD candidates,
expansion of both UCCOM and CCHMC facilities, design and implementation of a web-based physician
scientist specific individual development plan (IDP), design and implementation of the MSTP Transition Series
designed to provide targeted and enhanced guidance at each transition point during MSTP training. We are
confident that we can continue to achieve our aims and meet the central goal of our program. Towards this
goal, we are requesting support for 10 positions.

Public health relevance
Project Narrative The need for investigators who are well trained in both basic science and clinical research has been and continues to be an unmet need. NIGMS Medical Scientist Training Programs (MSTP) were developed to meet the need for more physician scientists and offer unique training opportunities. The UCCOM MSTP has been successful with 79% its graduates in careers consistent with their training as physician scientists.